The Role of VAP Membrane Contact Sites in Axonal Calcium Dynamics and Synaptic Transmission

Project Summary
The neuronal endoplasmic reticulum (ER) extends throughout the cytoplasm and forms extensive physical
contacts with organelles, even within specialized compartments like the presynaptic terminal. These contact sites
between the ER and other organelles are termed membrane contact sites (MCSs). MCSs are held together by
tethering proteins and are proposed to contribute to at least three cellular functions: trafficking of lipids, organelle
positioning, and exchange of calcium (Ca2+) ions. During action potential (AP) signaling, the influx of Ca2+ through
voltage-gated Ca2+ channels forms localized Ca2+ microdomains. These Ca2+ microdomains are critical for
synaptic vesicle fusion, signaling through Ca2+-sensitive proteins, and organelle function. MCSs are thought to
contribute to Ca2+ exchange by recruiting ER-bound proteins and organelles to Ca2+ microdomains, although it
is unclear which organelles are most reliant on tethering to the ER. A fundamental gap exists in understanding
the molecular composition and function of tethering proteins in the axon. The development of optogenetic Ca2+
indicators of different affinities has provided unprecedented opportunities to study how MCSs in the axon link
electrical activity with Ca2+ signaling to support synaptic function.
VAMP-Associated Protein (VAP) is a highly conserved ER tethering protein that binds numerous intracellular
targets. In the axon, VAP forms a unique MCSs by binding to voltage-gated potassium (Kv) channels Kv2 at the
plasma membrane (PM). Disrupting these ER/PM MCSs by knocking down Kv2 channels impairs synaptic
vesicle exocytosis by ~50% and requires VAP interactions in the Kv2 C-terminus. Unexpectedly when VAP is
knocked down in excitatory neurons, there is no change in AP-evoked cytosolic Ca2+ despite a ~50% impairment
in exocytosis. The central hypothesis is that Kv2/VAP MCSs are an essential structural component of presynaptic
terminals for Ca2+ signaling microdomains to support synaptic function. The overall objective is to determine at
what level membrane tethering affects synaptic function. The long-term goals are to determine how membrane
tethering informs synaptic strength and how dysregulation of these processes are involved in disease.
Aim 1 will determine how VAP domains contribute to synaptic function using optical indicators of synaptic vesicle
exocytosis. Aim 2 will determine how VAP MCSs influence Ca2+ dynamics within axonal organelles using
subcellular optical indicators of Ca2+. Given the complexity of this system and the essential nature of electrical
signaling in excitable cells, it is unsurprising that mutations in VAPB are implicated in several diseases including
familial amyotrophic lateral sclerosis. There is a critical need for a better understanding of the role of membrane
tethering in intracellular Ca2+ dynamics in the axon that we know is critical for synaptic function.

Public health relevance
Project Narrative This project will investigate the role of ER-resident membrane tethering proteins, VAMP-Associated Proteins (VAPs), in regulating the structural organization of presynaptic terminals through subcellular calcium dynamics. Dysregulation of plasma membrane function or intracellular signaling profoundly affects numerous neurological disorders. However, less is understood about how tightly coupled action potential signaling and intracellular chemical signaling occur during neuronal function.